Determining the role of cortical acetylcholine in fast waking state transitions

ABSTRACT
The brain naturally transitions between a variety of states throughout the day, and these brain states affect the
way information is processed. Within the state of wakefulness there are subtle, transient substates which
fluctuate on a seconds-long timescale and are accompanied by rapid changes in sensory processing. By gaining
a better understanding of the mechanism behind these spontaneous fast waking state transitions, we may be
able to explain more of the variability in the brain’s performance under different circumstances, and gain more
detailed insight into how different modes of information processing are being produced. Neuromodulators such
as acetylcholine (ACh) are well-known to play a role in driving the neural patterns which define distinct brain
states. However, due to limitations in methodology, it has yet to be determined whether ACh is involved in the
fast shifts in state seen within wakefulness. Now that recent technological advances allow these limitations to be
overcome, we aim to test the hypothesis that cortical ACh is indeed involved in these fast shifts in waking states.
The goal of this project is to determine when and where ACh is available to act in the cortex in relation to
behavioral and neural signatures of state, and investigate how these patterns of availability change in a disease
state. Specifically, this project aims to determine the spatial scale at which spontaneous cortical ACh activity is
homogeneous, the temporal scale of ACh availability in relation to activity of the basal forebrain, how patterns of
spontaneously fluctuating cortical ACh availability relate to neural features of brain state, and how the
relationship between ACh and behavioral features is altered in a disease state. Answering these questions will
help to inform us how different brain states arise and lead to variability in information processing, as well as fill
in knowledge gaps regarding the dynamics of neuromodulator availability in general.

Public health relevance
PROJECT NARRATIVE In order to explain why the brain processes information differently under different internal conditions, such as when an animal is sleepy vs. aroused, we need to get a better understanding of the neural mechanisms behind these substates of wakefulness. We hypothesize that the neuromodulator acetylcholine is specifically involved in driving the distinct neural patterns that define these waking substates, but so far limitations in methodology have prevented this direct relationship from being elucidated. By utilizing recent advances in biosensing technology to directly measure acetylcholine in the cortex, we plan to precisely define how local availability of this neuromodulator is related to neural and behavioral features of waking substates so that their underlying mechanism can become more clear.